Manipulation of the gut microbiome to delay breast cancer onset and progression in the context of weight loss and obesity

Summary
Bariatric surgery is associated with reduced breast cancer (BC) risk, improved outcomes, and increased
immunotherapy efficacy, but mechanisms remain undefined. By examining the underlying mechanisms of
bariatric surgery-induced protection, novel therapeutic approaches may be identified to benefit both lean and
obese patients. Long-term changes in gut microbiome composition and abundance persist at least 5 years post
bariatric surgery, which I posit will result in modulation of circulating microbially derived metabolites. Microbially
derived metabolites, including short chain fatty acids, secondary bile acids, and amino acids, are produced or
modified by gut microbes. These metabolites can act locally in the gut and circulate systemically as endocrine
signaling mediators to modulate host energy metabolism, immune homeostasis, and, presumably, anti-tumor
immunity. Preliminary data suggests that depletion of secondary bile acids in combination with elevation of
branched chain amino acids increased tumor immune infiltration and mediated increased response to αPD-L1
immunotherapy. Additional exciting preliminary data demonstrates that transfer of gut microbiota from bariatric
surgical weight loss mouse and human donors to non-surgical recipient mice decreased tumor burden. However,
the precise interactions between the gut microbiome, microbially derived metabolites, and immune function in
BC remains unclear and will be investigated in this F31 proposal. I hypothesize that modulation of the gut
microbiota will identify specific metabolites activating anti-tumor immunity that mimic the effects of bariatric
surgery. Aim 1 will determine the contribution of gut microbiota to improved outcomes of BC after bariatric
surgery. Fecal microbial transplant (FMT) will investigate to what extent microbiota can transfer bariatric surgery-
associated anti-tumor efficacy from donor mice to reduce cancer burden in recipients. Complementary models
in ER+ and ER- BC will allow me to compare impacts on different BC subtypes. Existing patient fecal samples
pre- and post-bariatric surgery will next be examined by FMT to identify conserved microbiome changes with
strong mechanistic potential in BC. Aim 2 will determine the impact of secondary bile acids on BC progression
using complementary in vivo models and innovative in vitro approaches. Taken together, this proposal will define
the effects of microbially derived metabolites on the tumor microenvironment, especially regarding obesity and
immunity. This study builds upon my previous experience in microbiology and in vitro organoid modeling to shape
a highly competitive skill set focusing on microbiome – immune system interactions through diverse yet
complementary training incorporating bioinformatics analysis and wet lab techniques in the fields of microbial
genetics and immunology. This F31 will train me as an expert in the gut microbiome, a rapidly evolving area of
research with strong therapeutic potential to help treat patients with BC and other diseases. The proposed cross-
disciplinary training defined in this F31 will prepare me for my long-term goal of becoming an independent
investigator at an academic institution.

Public health relevance
Narrative A history of bariatric surgery is associated with reduced risk and improved outcomes in patients with subsequent diagnosis of breast cancer; hence, my goal is to identify mechanisms underlying this long-lasting protection. Bariatric surgery causes a sustained reduction of obesity-associated dysbiosis of the gut microbiome, which I hypothesize primes the microbially derived metabolite profile to activate anti-tumor immunity. This project will define impacts of microbially derived metabolites on the tumor microenvironment, especially with regards to obesity and immunity and will position me in an exceptionally strong and strategic position in the emerging fields of microbiome and anti-tumor immunity.